Automated Assessment of Cognitive Tests for Detecting Mild Cognitive Impairment

SUMMARY Detecting the first and earliest stages of cognitive decline, conceptualized as “mild cognitive impairment” (MCI), has become increasingly important in recent years, as research focuses on delaying the manifestations of more severe stages of decline. It is now well recognized that changes in performance on cognitive tests begin up to ten years (or longer) before clinically apparent symptoms of dementia or functional impairment appear. Conventional assessment methods for assessing cognition Conventional assessment methods typically use the spoken response modality in which subjects are asked to verbally respond to prompts, and examiners carefully listen to these responses and apply test manuals to compute scores. These assessment methods require trained specialists and can be burdensome because they need to performed in clinics, especially so with frequent reassessment. Automating the scoring of assessment is important, not only for alleviating this burden but also for enabling large-scale studies on new intervention methods. Our research goal is to automate detection of MCI by developing, applying, and evaluating a system for automation of verbal (i.e., using spoken responses) cognitive-test scoring. Focusing on four verbal cognitive tests, we develop an extensible system comprising ASR and machine-learning algorithms to automatically score responses, and measure the efficacy of our proposed method by validating the accuracy of the automatically obtained scores against gold-standard, clinically obtained scores (Aim 1). Next, we develop classification methods for detecting individuals with MCI based on all information available in the verbal responses, and validating this classification against gold-standard clinical consensus.

Public health relevance
NARRATIVE Early detection of mild cognitive disease (MCI) is significantly important to delay more severe stages of cognitive decline. Conventional assessment methods require trained specialists and can be financially beyond the reach of most. We propose a tool for automatically scoring verbal cognitive tests. The proposed tool can be embedded in electronic devices providing the opportunity to assess large number of people in their homes, enabling clinicians to focus on those who are most at risk of cognitive decline.